Defining the neovaginal microbiome after gender affirming vaginoplasty

Project Summary
It is estimated that up to 0.6% of the US population is transgender, which describes someone whose
gender identity is incompatible with their sex assigned at birth. Gender affirming medical care can include
vaginoplasty, which is the surgical creation of a vulva and neovagina. Transgender women have increased odds
of testing positive for sexually transmitted infections (STIs) including human immunodeficiency virus (HIV)
compared to cisgender women, which is maintained after adjusting for high-risk behaviours, suggesting
biological factors unique to the neovaginal microenvironment may contribute to this increased risk. Despite this,
little is known about the neovaginal microenvironment, which could have important implications for both post-
operative care and long-term mucosal health of people with neovaginas.
The neovaginal microbiome is not well-defined, but typically has greater microbial diversity compared to
the natal vaginal microbiome, and contains species that are more typically detected in the penile, intestinal and
skin microbiomes. In cisgender women vaginal microbial dysbiosis has been linked to increased genital
inflammation, gynecological symptoms, and an increased risk of acquisition of STIs including HIV, but it is
unknown if the neovaginal microbiome has a similar impact on gynecological health. A major gap in knowledge
is defining the optimal neovaginal microbiome, including an understanding of the colonization and stability,
and relationship to gynecological health, which is vital for care of people with neovaginas. Indeed, current
post-operative and long-term care recommendations differ greatly between surgical centers. In this proposal we
will define the neovaginal microbiome in transgender women who have undergone (“post-op”) or are scheduled
to undergo (“pre-op”) vaginoplasty, and investigate associations of the microbiome to genital inflammation and
clinical outcomes including gynecological symptoms.
This study will be the first to comprehensively profile the neovaginal microenvironment, which is critical
to provide evidence-based care guidelines to people with neovaginas.

Public health relevance
Project Narrative Transgender women have disproportionally high rates of sexually transmitted infections including human immunodeficiency virus, which is maintained after adjusting for high-risk behaviours. Little is known about the neovaginal microenvironment following gender affirming vaginoplasty, which could have important implications for mucosal health in transgender women. In this project we will profile the neovaginal microbiome and its’ association with inflammation, bacterial functions, and gynecological symptoms.